School-based policy influences on preconception cardiovascular health

Project Summary
Cardiovascular-related complications are a leading contributor of U.S. maternal morbidity, of which women of
color bear the disproportionate burden. Current approaches to intervene on perinatal cardiovascular health
emphasize prenatal lifestyle and pharmacological interventions. Given the considerable time needed to
achieve optimal health, these approaches have been characterized as “too little, too late” to meaningfully
reduce maternal morbidity such as gestational diabetes, pre-eclampsia, macrosomia, and preterm birth.
Adolescence is a crucial period to establish optimal health trajectories to avert later life health risks. One in five
adolescent girls in the U.S. is obese and nearly one in three have prediabetes, which suggests escalation of
the maternal health crisis. Schools are arguably one of the most important levers available to policymakers to
influence adolescent cardiovascular health. Prior research on schools has documented associations between
aspects of the built, food, social and learning environments on adolescent obesity. Yet disparities in the
`healthfulness' of school environments have also been documented by school-level socioeconomic and
racial/ethnic composition, with lower income schools typically equipped with fewer physical activity and
extracurricular resources. Rarely, has research considered the influence of school attributes on cardiovascular
risk trajectories outside of obesity, examined the implications for later maternal morbidity or applied a health
equity implementation framework to school policy development. We propose a mixed-method study to
construct a school-based adolescent preconception cohort through innovative data linkages, engage
adolescents and local stakeholders to develop acceptable school-based policy solutions to achieve health
equity, and utilizes an innovative approach to capture school system dynamics using agent-based modeling.
Our overall goal is to identify school policy interventions to avert excess cardiovascular and maternal health
risk and to narrow racial/ethnic inequities. In Aim 1, we will assess the association between
school attributes, adolescent cardiovascular risk and maternal morbidity at first birth by creating a school-
based adolescent preconception cohort that leverages existing data on school environments, adolescent
health and fitness records, and Medicaid birth claims data between 2008 and 2024. In Aim 2, we will engage
adolescents and local stakeholders to co-design school-based solutions to improve adolescent and perinatal
cardiovascular health using a participatory systems dynamic method, group model building. In Aim 3, we will
test promising school-based solutions using agent-based modeling to inform later life health outcomes.
Findings will inform actionable policies to transform school environments with the goal of disrupting lifecourse
trajectories that lead to racial/ethnic disparities in maternal health and beyond.

Public health relevance
Project Narrative The rising prevalence of adolescent obesity and prediabetes, affecting 20% and nearly 30% of girls respectively, may fuel the contribution of cardiovascular-related complications in the maternal health crisis, which disproportionately affects women of color. Schools are a prime context to shape health behaviors and promote positive trajectories of health yet have been largely unexplored in connection to future maternal health. We propose a mixed-method study that leverages innovative data linkages to establish a school-based adolescent preconception cohort with 14 years of follow-up, engages adolescents and local stakeholders to co- design acceptable school-based policy solutions to achieve health equity, and utilizes an innovative system science approach to assess the long-term maternal health outcomes of policy solutions.